Mentoring in Addiction Treatment Research

7. Project Summary: I am a psychiatrist serving as director of the Massachusetts General Hospital (MGH) Center for Addiction Medicine (CAM) and Associate Professor of Psychiatry at Harvard Medical School (HMS). I have conducted NIDA sponsored patient oriented addiction research (POAR) since 1999. From 2001-2006, I was supported by a NIDA K23 award that enabled me to earn a masters degree in public health and to conduct mentored clinical research in nicotine dependence treatment. In 2005, I was asked to direct the MGH CAM and began to build a thriving clinical research program and to spend significant time mentoring junior investigators. My research has focused on discovery of novel pharmacologic and behavioral treatments for nicotine dependence in those with and without major psychiatric illnesses. I currently serve as principal investigator (PI) for two NIDA R01 and one NIDA R21 grant awards and am Co-PI and Project PI for the NIDA U01 Cooperative Drug Discovery for the Treatment of Nicotine Addiction (CDDG-ND). I have established a group of fifteen junior investigators working collaboratively in the context of my funded research to translate recent advances in neuroscience to the study and treatment of addictions. I work in a rich environment for clinical research. I receive no institutional support for mentoring and will be required curtail my mentoring effort in order to assume significant clinical responsibilities beginning in 2011. The K24 award will protect time that would otherwise be diverted to clinical responsibilities to allow me to continue to provide intensive ongoing mentorship to junior investigators in POAR and to spend more effort attracting excellent junior researchers to POAR, while devoting 45% effort to conducting independent, peer-reviewed POAR to discover novel treatments for nicotine dependence. My long term career objectives are: 1) To improve outcomes for adults with nicotine dependence by developing and testing novel pharmacologic and behavioral interventions and developing algorithms to tailor these interventions to increase cessation rates and reduce relapse in individuals; 2) To improve our knowledge base of how to effectively treat nicotine dependence in smokers with co-morbid mental illness; 3) To develop therapies for nicotine dependence that act upon basic mechanisms such that they are effective for other addictive disorders; and 4) To contribute to the development of early career investigators in clinical addiction research by providing mentored research opportunities. The specific aims to be accomplished during the period of the award are to 1) Develop specific expertise in clinical research applications of neuroimaging and genetics in order to enhance ongoing and future research in development and testing of novel treatments for prevention of relapse to smoking and development of a knowledge base to guide patient-centered nicotine dependence treatment. 2) Protect time for substantive mentoring of junior investigators. 3) Continue and extend involvement in POAR. To accomplish these goals, I will devote 20% effort to new training, 30% effort to substantive mentoring of junior investigators, and 45% effort to funded POAR.

Public health relevance
Project Narrative Each year over 430,000 people in the US die from smoking-related illness; the annual global mortality toll is over 5 million, and 500 million existing cigarette smokers will die of causes that could be prevented by treatment of their addiction to tobacco-delivered nicotine. This K24 award will support mentoring and training of talented clinical scientists to discover novel treatments for smoking cessation and prevention of relapse to smoking that would not otherwise be supported. __SpecificAimsTextDelimiter__ 10. Specific Aims: I will use the K24 award to support my effort in POAR mentoring (30%) and training in methodologies that will improve and extend my research (20%), both of which will be synergistic with the 45% effort I will devote to conducting externally funded POAR. In total, I will spend 95% of my professional effort in POAR and mentoring. I will spend the remaining 5% effort administering the MGH CAM, ARP, and serving on the HMS Addiction Fellowship Training Committee and the HMS Fellowship Selection Committee. I will receive new administrative support from the Department of Psychiatry for this latter role, which also is synergistic with my K24 goals in mentoring, both in attracting high quality trainees and junior faculty across HMS Institutions and beyond and in providing access to research and career development resources for my trainees. Aim 1. Develop specific expertise in clinical research applications of neuroimaging and genetics in order to enhance ongoing and future research in development and testing of novel treatments for prevention of relapse to smoking and development of a knowledge base to guide patient-centered nicotine dependence treatment. I will undergo tutorials and didactic training, outlined in detail in Section 4 of the proposal, in order to acquire specific expertise in clinical research application of genetics, particularly pharmacogenetics, and neuroimaging, particularly fMRI, that I will apply in ongoing and future clinical trials of novel pharmacotherapies for prevention of relapse to smoking in order to improve my ability to identify contributors to individual variability in treatment response and to build a knowledge base for nicotine dependence treatment algorithms. This work will take place in the context of ongoing and new proposed studies, e.g. P50 029957. This new learning will culminate in Years 3-5 of the award in a new research proposal proposing a fully powered clinical trial using RTfMRI as a behavioral treatment intervention and a new research proposal to test a patient-centered therapy model for nicotine dependence treatment assignment using baseline predictors for differential treatment response. Aim 2. Protect time for substantive mentoring of junior investigators in POAR. The K24 award will protect time that would otherwise be diverted to clinical responsibilities to allow me to sustain and intensify ongoing mentorship to junior investigators in POAR and to spend more effort attracting excellent junior researchers to POAR. Such mentorship will often take place in the context of ongoing funded research, such that more intensive mentorship will directly increase the quality and output from my ongoing POAR. I will devote 30% effort to mentoring junior researchers as outlined in detail in Section 6. Aim 3. Continue and extend involvement in POAR. The K24 will allow me to extend my POAR by protecting time that will allow me to work with mentees on funded projects, ancillary projects, secondary data analyses, papers and grant proposals that will add value to ongoing, externally-funded POAR. In addition, the K24 will protect time for me to develop skills that will improve the quality and increase the impact of ongoing and proposed projects. Thus the training and mentoring activities funded by the K24 will directly benefit, enhance and increase the impact my ongoing and future POAR. Overall, I will spend 45% effort engaging in ongoing peer reviewed research, initially consisting of research supported by grants U01 DA19378 (Co-PI and Project PI) CDDG-ND, R01 DA021245 (PI) Extended Duration Pharmacotherapy for Smoking Cessation and Relapse Prevention in Schizophrenia, R01 DA022276 (PI) Glycine Transport Inhibition for Smoking Cessation in Schizophrenia, and a privately funded project: Enhancing Self Control of Tobacco Craving with RT-fMRI. In latter years of the award, this effort will be supported by additional grants submitted and planned. Additionally, in order to develop methods that can be used to further my goal of developing patient- centered approaches for nicotine dependence treatment, research funds from the K24 will be used to develop novel statistical modeling methods that I will use to increase our understanding of individual factors contributing to variability in nicotine dependence treatment response and relapse. Such modeling methods will enable me to discover whether individual traits, measurable prior to therapy, can be used to direct therapeutic decision- making for individuals. We will test modeling methods with an existing, publicly available dataset with a large number of baseline variables from the Treatment of Adolescent Depression Study (TADS)80,81 In pilot modeling work, David Schoenfeld developed a method to assign therapy based on baseline clinical factors and found that average improvement using the model to assign each patient to their optimal therapy from among the four treatments (fluoxetine, CBT, fluoxetine + CBT or placebo) appeared to be superior to the clinical improvement observed with those randomly assigned to the best treatment in the trial (fluoxetine + CBT)21. Support is needed to refine this method, publish a methods paper, and apply the refined model method, developed and tested with the TADS dataset, to results from the clinical trials conducted in the U01 CDDG-ND. Predictors identified in the CDDG-ND trials will be prospectively tested in a trial to be proposed in the latter years of the award that will randomize with and without modeling. Statistical methods development is beyond the scope of my funded and requires additional funding. K24 funding is appropriate as the resulting methods will advance my long-range scientific goals. Dr. Schoenfeld will devote 3 hours / week to this endeavor, and his colleague, Dr. Rui Wang will devote 5 hours / week. We will meet regularly to discuss issues and progress of methods design and feasibility, analysis, and interpretation.